Identifying and Addressing Barriers in the Cervical Cancer Treatment Cascade among Women with HIV in South Africa

PROJECT SUMMARY/ABSTRACT
The vast majority of women who develop and die from cervical cancer live in low- and middle-income
countries.1 In sub-Saharan Africa, geographic inequities in rates of cervical cancer are fueled by high HIV
incidence and prevalence among women with HIV (WWH). South Africa (SA) bears the greatest HIV burden in
the world2 and has the highest cervical cancer incidence rate globally;3 in SA, 53% of all cervical cancer cases
are attributable to HIV.4 With increased attention paid to the importance of cervical cancer screening (which, in
SA, is typically cytology-based via Pap smears),5 Pap smear screening rates have risen; as of 2018, 52% of
women had been screened,6 up from 18-25% in earlier studies.7 However, cervical cancer can only be prevented
if patients are retained in care and subsequently treated. Alarmingly, only 26% of WWH who received high-risk
abnormal Pap results completed medically-required follow-up and management within 18 months.8
To increase retention of WWH in the cervical cancer treatment cascade, it is imperative that we investigate
the specific factors that negatively affect follow-up appointment attendance and engagement with necessary
treatment. Without a nuanced understanding of barriers to retention and treatment across multiple levels, WWH
will continue to be at disproportionate risk for cervical cancer.
A multi-level retention care intervention that is tailored to the unique needs of WWH who have recently
received high-risk abnormal Pap results has strong potential to mitigate massive cervical cancer disparities. We
now propose to conduct the formative work that is necessary to develop the novel intervention, which, in line
with PAR-21-341, will modify the complex, intersecting factors that contribute to cervical cancer development
among WWH. In qualitative interviews with (1) WWH (n<10) who had a high-risk abnormal Pap smear in the
past six months and have not yet attended a follow-up visit and (2) WWH (n<10) who had a high-risk abnormal
Pap smear in the past six months and have attended at least one follow-up visit, we will explore the individual,
interpersonal, clinic-level, and structural barriers and facilitators to follow-up appointment attendance and
subsequent treatment. Intervention preferences will also be probed. In separate interviews with providers (n<8),
we will explore their perspectives on barriers to delivery of care and barriers to retention of patients in care post-
abnormal Pap smear. The qualitative data will inform the specification of the multi-level intervention, which will
be tested in a pilot randomized controlled trial (n=60). Feasibility and acceptability will be the primary study
outcomes, which will be assessed among both patients and providers. We will also assess for signals of clinically
meaningful differences in (1) the proportion of women who attend a follow-up appointment (and, of those, the
proportion who complete the next phase of treatment, which will be exploratory), and (2) self-efficacy to attend
a follow-up and/or other cervical cancer-related appointments. If deemed to be feasible and acceptable, with
preliminary signals of efficacy, the intervention will be ready for an R01-level hybrid efficacy/effectiveness trial.

Public health relevance
PROJECT NARRATIVE In South Africa, women with HIV (WWH) are at a dramatically elevated risk for cervical cancer, which is preventable through timely screening and treatment of precancerous lesions; however, screening via Pap smears is only effective if women are retained in care, and unacceptably high rates of WWH with abnormal Pap smears are lost to follow-up. This study will (1) explore the barriers and facilitators to follow-up appointment attendance and subsequent treatment among WWH with a recent high-risk abnormal Pap smear and their providers; (2) develop a multi-level intervention to increase follow-up appointment attendance and subsequent treatment; and (3) evaluate the feasibility and acceptability of the intervention in a pilot randomized trial. If feasibility, acceptability, and preliminary efficacy are demonstrated, then the intervention will be ready for large- scale efficacy/effectiveness testing, with the ultimate goal of decreasing the incidence of cervical cancer among WWH.